Psychosocial and cultural determinants of cardiometabolic health among older Chinese Americans

Project Summary
Cardiometabolic diseases contribute to more than 1 in 4 deaths in U.S. adults, including Asian Americans.
Psychosocial stress is a key risk factor leading to elevated risks of cardiometabolic diseases. However, there is
limited knowledge of how psychosocial stress affects cardiometabolic health among Asian Americans,
especially older foreign-born Asian Americans who disproportionately encounter psychosocial stress due to
racism, language barriers, and low socioeconomic status. Notably, a lack of knowledge of key biobehavioral
mechanisms through which psychosocial stress affects cardiometabolic health hampers public health efforts to
develop effective interventions to promote cardiometabolic health in the understudied Asian American
population, which is projected to reach 46 million by 2060. To address these important scientific gaps, the
proposed study is to investigate key biobehavioral processes through which daily psychosocial stress affects
cardiometabolic health among 300 older foreign-born Chinese Americans. We will use a prospective design
and harness the power of ecological momentary assessment and biospecimen sampling to achieve study
aims. We propose to: (Aim 1) investigate day-to-day associations among psychosocial stressors (e.g., social
isolation), biobehavioral processes (e.g., salivary diurnal cortisol) and blood pressure, and (Aim 2) examine the
moderation roles of sociocultural factors (e.g., filial piety, acculturation) on the longer-term effects of
psychosocial stressors on cardiometabolic health over two years. Completion of the proposed study will
generate new knowledge to facilitate the understanding of the interplay of psychosocial stress and
sociocultural factors in determining cardiometabolic health and their underlying mechanisms in older Chinese
Americans. As a result, this project will guide the design of future culturally relevant, personalized
psychobehavioral interventions that aim to promote cardiometabolic health in this at-risk but underserved
population.

Public health relevance
Projective Narrative Examining biobehavioral mechanisms through which psychosocial stress contributes to poor cardiometabolic health in older Asian American immigrants is a critical area for public health, as cardiometabolic diseases are leading causes of death among Asian American immigrants. This study will adopt a prospective design to investigate the psychosocial and cultural determinants of cardiometabolic health and key biobehavioral processes underlying these relationships. Study results will inform future culturally relevant public health interventions to promote cardiometabolic health for older Asian American immigrants.